The role of SRCAP in therapy related clonal hematopoiesis

PROJECT SUMMARY
Therapy-related myeloid neoplasms (t-MN) arise following the administration of chemotherapy or radiation and
are a devastating complication of treatment given to cure cancers and treat other inflammatory conditions. There
remains a gap in our understanding of how t-MNs arise and, thus, how we can better identify patients at the
highest risk of developing them and prevent their development. Many t-MNs evolve from pre-existing clonal
hematopoiesis (CH), a pre-malignant state, that develops or expands in the setting of cytotoxic therapy exposure.
The long-term goal is to understand better the processes that drive clonal selection in the hematopoietic system,
thus the development of CH and evolution to t-MN. The overall objective in this application is to understand how
mutations in SRCAP, a gene recurrently mutated in CH among therapy-exposed patients (t-CH), promotes
hematopoietic cell expansion and pre-malignancy. SRCAP encodes for a conserved ATPase that deposits the
histone variant H2AZ on chromatin and plays essential roles in the epigenetic regulation of transcription and
DNA repair. The central hypothesis is that loss of SRCAP dysregulates the DNA damage response (DDR) by
altering deposition of H2AZ at sites of DNA double-strand breaks and at the promoters of genes involved in the
DDR and thus confers resistance to cytotoxic agents leading to the clonal outgrowth of mutant hematopoietic
stem and progenitor cells. Guided by robust preliminary data and the development of a novel conditional
knockout mouse model, this hypothesis will be tested by pursuing three specific aims: 1) Study the role of SRCAP
in hematopoiesis during normal and stressed states using a novel conditional mouse model; 2) Determine how
SRCAP regulates the response to DNA damage; 3) Determine how Srcap mutations influence the evolution and
clonal expansion of t-CH. In the first aim, a novel conditional Srcap knockout mouse has been generated and
will be used to study the role of SRCAP during normal hematopoiesis and during cytotoxic therapy-induced
stress. This mouse is currently in the lab and available for use. In the second aim, the role of SRCAP in regulating
the response to cytotoxic therapies and the DNA damage response pathway in both human and mouse cell lines
will be evaluated. Finally, in aim 3, the evolution of t-CH will be assessed by generating mice with mutations in
Srcap and other genes recurrently mutated in CH and myelodysplasia to evaluate effects on hematopoiesis. The
approach is innovative because it utilizes a novel conditional mouse model and provides the opportunity to study
both the regulation of the DDR and epigenetic regulation of hematopoietic stem and progenitor cells, two
processes known to be essential mediators of disease in CH and myeloid malignancies. The proposed research
is significant because it will expand our understanding of how hematopoietic cells evolve in the setting of cytotoxic
therapy and the role of SRCAP in normal and stressed hematopoiesis. Ultimately, this knowledge may provide
new opportunities to develop strategies for the early detection and prevention of t-MNs.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because understanding how cytotoxic therapy-induced stress promotes clonal hematopoiesis and the development of hematologic malignancies will help identify patients at the highest risk of disease progression and promote the development of novel strategies directed at prevention and treatment. Thus, this proposal is relevant to the NIH's mission to develop fundamental knowledge that will help to reduce the burdens of human disease.